Uncovering the regulatory logic of gene expression encoded by disordered regions

Cellular state, identity, and function are primarily determined by the genes expressed at a given
moment. Many diseases are characterized by dysregulation of gene expression, leading to
inappropriate gain/loss of function that can drive proliferative growth (cancer), impede
homeostasis (neurodegeneration), or rewire the immune response (viral infection). Limitations in
our understanding of the complex, pleiotropic, and inherently adaptive molecular mechanisms
that underlie pathological changes in gene expression are a significant barrier to our ability to
design effective therapeutic strategies to alleviate these conditions.
Eukaryotic gene expression is a coordinated event driven by an array of cellular processes.
Among the various molecular components, transcription factors are arguably the core
determinant of expression. Transcription factors are modular proteins that possess DNA-specific
binding domains and facilitate the recruitment of additional co-factors that drive (or occasionally
suppress) gene expression. Our understanding of how the folded DNA binding domains
recognize consensus DNA binding sites is relatively mature. In contrast, we lag behind in a
high-resolution understanding of other domains' various roles. Of particular interest,
transcription factors are enriched for intrinsically disordered regions. These regions are often
considered to play a role in driving gene expression as “activation domains” - regions that
determine the strength of gene expression. However, both numerous high-throughput studies
and systematic bioinformatic analyses predict that, on average, only 15% of any given
transcription factor is strictly required for robust gene expression. This raises a question: what is
the remaining 85% of each transcription factor IDR doing?
This proposal centers on the discovery that transcription factor IDRs play a second, previously
unappreciated role in coordinating gene expression. We will dissect this new role to decode the
underlying molecular logic. This will involve using rational sequence design to probe the
sequence-determinants of gene expression through a novel library-based approach. This will be
combined with in vitro and in silico analyses to disentangle the molecular basis for our
observations. Our ultimate goal is to understand how the mutations that appear in transcription
factors IDRs can alter gene expression in non-intuitive and pathological ways.

Public health relevance
Transcription factors are proteins that determine which genes are turned on or off in a cell at any given moment. Mutations in transcription factors cause many diseases (notably cancer), yet because we often don’t understand how these mutations influence transcription factor function, we generally don’t have good ways to interpret why these mutations cause disease. Here, we have discovered a previously uncharacterized layer of regulation in transcription factor-mediated gene expression, which we will dissect to better understand how mutations cause human disease.